Center for Leadership in Environmental Awareness and Research

Abstract: Evidence suggests that exposure to volatile organic compounds (VOCs), such as benzene, toluene,
ethylbenzene, and xylene (BTEX), trichloroethylene (TCE), and tetrachloroethylene (PCE), is an important
determinant of maternal-offspring health, with implications for preterm birth (PTB) and associated adverse
health outcomes. VOCs emanate from landfills, brownfields, and Superfund sites, contaminating shallow soils
and groundwater below residential, commercial, and industrial properties, leading to exposures via vapor
intrusion. The Center for Leadership in Environmental Awareness and Research (CLEAR) is dedicated to
understanding and mitigating this serious environmental health problem with a focus on post-industrial urban
centers. Headquartered in Detroit, Michigan, CLEAR will use Detroit as a study site, which has the highest PTB
rate in the country (15.2%) and is located in a state where 37 of the 67 Superfund sites must manage VOC
contamination. CLEAR hypothesizes that VOC exposure through vapor intrusion during early life incites
inflammatory responses in maternal tissues and/or the developing offspring that re-program the developing
immune and other critical systems, setting the stage for PTB and/or associated adverse health outcomes. Five
integrative environmental science and engineering and biomedical research projects (E1, E2, B1, B2, B3),
supported by five cores, will investigate toxic mechanisms, exposure pathways, biomarkers, and strategies to
prevent exposures and improve public health outcomes by: (1) developing and testing new detection
methodologies, including phytoscreening (E1); sensor technology that integrates Internet of Things and edge
computing for real-time contaminant detection and rapid-response, mitigation, and remediation (E2); and a
controlled toxicity bioassay using WSU-designed sealed chambers for evaluating reproductive, neurological,
behavioral, immunological and multigenerational responses in zebrafish (B1); (2) studying mechanistic effects
of VOC exposure in a pregnant mouse model (B2); (3) applying epidemiologic methods for estimating
exposure effects via human biological specimen analysis (B3); applying advanced chemical analysis, statistical
approaches and visualization tools to obtain and integrate project data (Chemical Analysis, and Data
Management and Analysis Cores), thereby establishing the impact of VOC exposures on PTB and associated
adverse health outcomes; (4) creating an innovative model for transdisciplinary education and workforce
diversity by engaging new trainees to solve complex environmental health problems (Research Experience
and Training Coordination Core); (5) engaging stakeholders and the community to inform our inquiry/analysis,
participate in sampling, and employ health interventions (Community Engagement Core); and (6) uniting
around an Administrative Core that conducts targeted research translation to ensure a legacy of scientific
awareness and supports the Superfund Research Program to improve public health in urban centers impacted
by environmental contamination to protect affected communities.

Public health relevance
Project Narrative The Center for Leadership in Environmental Awareness and Research (CLEAR) proposes an integrated, transdisciplinary framework, rooted in advanced techniques in environmental engineering and biomedical research, to address human exposure routes and health risks from volatile organic compounds (VOCs) in urban areas. Research findings on (a) the relationship between VOC exposure and human health risks—for preterm birth and associated adverse health outcomes in particular—combined with (b) new methods and technologies to assess, communicate, and reduce those health risks, and (c) a new understanding of related biological systems, will contribute to improved public health interventions. CLEAR research is expected to have a direct impact on affected communities, stakeholders, and the agencies responsible for reduction of environmental VOC exposure and for Superfund site management.